Disability Perspectives on the Adverse Health Effects of Medical Ableism

PROJECT SUMMARY
A growing body of research shows that ableist attitudes and beliefs are widespread among healthcare providers and
that many healthcare settings still lack necessary accommodations for patients with physical, psychiatric, sensory,
neurological, and learning disabilities. This medical ableism likely contributes to the substantial health disparities
experienced by people with disabilities. However, public health research to date has not evaluated the frequency and
variety of medical ableism experiences among patients with disabilities, nor has it measured how these experiences
adversely affect the care and health of disabled patients. The long-term goal of our research is to develop a nuanced and
comprehensive understanding of medical ableism that will ultimately allow us to develop targeted interventions to
mitigate its effects on the care and health of people with disabilities. The objective of this observational study is to
conduct quantitative analyses of the medical ableism phenomenon and its impact on the healthcare and health
outcomes of people with disabilities. This research will move the field beyond abstract assessments of internal ableism
among providers by providing detailed evidence about how people with disabilities experience medical ableism. The
specific aims of the project are: 1) to create and field survey modules measuring medical ableism and its adverse care
and health impacts, 2) to characterize experiences of medical ableism, and 3) to identify the adverse care and health
impacts of medical ableism. These aims will be met using a large, diverse, and well-established survey developed by the
research team: the National Survey on Disability and Health (NSHD). The 5th wave of the NSHD is currently open, and
the previous wave had a sample size of 2,725 adults with a variety of disabilities, providing sufficient statistical power for
subpopulation analyses.
The project research team and its expert advisory panel, comprised solely of researchers with disabilities, will model
best practices in disability inclusion and representation in disparities research. It will offer researchers and advocates a
new, publicly accessible, and user-friendly data source on critical dimensions of medical ableism. The large and diverse
survey sample will allow users to explore intersections between disability and race, ethnicity, gender, sexual orientation,
and socioeconomic status. The survey questions can be adopted or modified by advocates to assess discriminatory
practices and environments among local healthcare providers. The findings will also allow educators to develop and
refine disability curricula and target anti-ableist practices in medical education. The project further the National Center
on Medical Rehabilitation Research’s mission to foster the development of scientific knowledge needed to enhance the
health, productivity, independence, and quality of life of people with disabilities.

Public health relevance
Project Narrative The proposed research is relevant to public health because it is the first study to systematically assess the prevalence of medical ableism and its consequences for patient care and health within a large and inclusive national sample of U.S. adults with disabilities. The long-term goal of our research is to develop a nuanced and comprehensive understanding of medical ableism that will ultimately allow us to develop targeted interventions to mitigate its effects on the health of people with disabilities. The project will model best practices in disability inclusion and representation, and further the National Center on Medical Rehabilitation Research’s mission to foster the development of scientific knowledge needed to enhance the health, productivity, independence, and quality of life of people with disabilities.